The effect of physical activity on cognition relative to APOE genotype (PAAD-II)

Project Summary: By 2050, the prevalence of Alzheimer’s disease (AD) in the United States is predicted to
reach 13.8 million. Despite worldwide research efforts, a cure for AD has not been identified. Thus, it is critical
to identify preventive strategies that can reduce the risk of or delay the onset of AD. Physical activity (PA) has
potential in this regard. Meta-analytic reviews and our own experimental studies show that older adults who
participate in PA experience larger gains in cognitive performance than do controls. Prospective studies also
show that PA is associated with a lower risk of AD and that the relationship between baseline PA and
subsequent cognitive performance is moderated by a susceptibility gene for AD (apolipoprotein, APOE). In a
Phase I proof-of-concept trial, we showed that individuals with a family history of AD (FH+) achieve cognitive
benefits in association with PA and that these benefits were even evident in those with a genetic risk for AD
(i.e., APOE e4 carriers, APOE4+). However, no published randomized controlled trial has assessed the effects
of PA on cognition in cognitively normal FH+ individuals relative to APOE4 status. In addition, in currently
funded trials beginning to address this gap, the focus is on older adults (65+); thus limiting the ability to identify
protective effects that may be more evident with earlier interventions. Lastly, current evidence does not
elucidate mechanisms to explain how PA benefits cognitive performance. These gaps in the literature have
motivated our Phase II trial, in which we extend our past work by proposing a randomized clinical trial to: (a)
test the causal link between PA and cognitive performance in middle-aged adults (40-65 years) with a FH+,
and (b) determine if the effect is moderated by APOE4 carrier status. We will collect neuroimaging measures of
cerebral structure, white matter integrity, and resting state connectivity; assess putative biological markers; and
(using moderated mediation analyses) increase understanding of underlying mechanisms and of the extent to
which effects are moderated by APOE4 carrier status. To test our hypotheses, we will randomly assign 240
cognitively normal, middle-aged adults to a 1-year PA program or a usual care control. We will assess
cognitive performance at pre-, mid-, and post-test, and obtain MRI scans and blood samples at pre- and post-
test. We will examine the effects of PA on cognitive performance and on neurological and biological
mechanisms and will explore the moderating role of APOE4. A strength of this study is that we incorporate
cognitive measures and MRI sequences used in a Phase III clinical trial (1R01AG053952) testing the effects of
PA on cognition in older adults (65-80 years), and we are collaborating with the PI of that trial (Erickson). This
will allow us to leverage NIH’s resources by compiling data across a broad age range. Importantly, findings
from this study may support PA as a means of improving cognitive performance by those with a heightened
risk for AD. This could have public health implications, because delaying AD by 1 year could reduce its
incidence by 11%.

Public health relevance
Project Narrative We propose a randomized clinical trial to test whether physical activity is linked to cognitive performance in middle-aged adults (40-65 years) with a family history of Alzheimer’s disease, and to determine if carrying the APOE epsilon 4 allele (linked to Alzheimer’s) affects this relationship. If our research is borne out, one day we may be able to prescribe a “dose” of physical activity to achieve cognitive benefits and to delay the onset of Alzheimer’s disease in persons with a heightened risk of this disease. Because delaying the onset Alzheimer’s disease by one year can reduce incidence by 11% and delaying by 5 years could reduce prevalence by 29- 43%, this research has important public health implications.